Improving the efficacy of mTOR inhibition

Glioblastoma (GBM), the most common primary brain tumor and among the most aggressive of cancers, is driven by
phosphatidylinositide 3-kinase (PI3K), AKT, and mTOR (mechanistic target of rapamycin) signaling. Inhibitors that
target PI3K-AKT-mTOR pathways are in clinical use or in development, however we have demonstrated previously that
inhibition of PI3K/AKT does not block downstream mTOR signaling in GBM, thereby limiting efficacy of PI3K/AKT
inhibitors. First generation mTOR inhibitors (rapamycin and rapalogs) selectively inhibit only one effector of the
mTORC1 protein complex1 (S6K1), with inhibition feeding back to activate PI3K/AKT signaling. Second generation
ATP-active site inhibitors of mTORC1/2 (MLN0128 and others) inhibit both effectors of mTORC1 (S6K1 and EIF4E)
and also block AKT. We show within that these are less effective than rapamycin in preclinical models of glioma in-vivo,
traced to poor pharmacokinetics. We tested a third generation mTOR inhibitor (Rapalink-1). Within, we show that
RapaLink-1 has mTORC1-specific binding and blood brain barrier permeability similar to rapamycin, uses mTORC1
selectivity both to potently block the catalytic ATP-binding site of mTOR within mTORC1, and to accumulate in brain
tumor cells. Consequently, Rapalink-­‐1 is more potent than rapamycin and shows better pharmacokinetics than MLN0128.
Revolution Medicine is developing such third generation mTORC inhibitors, and we are working with them to help
develop these agents for GBM. We hypothesize that third generation mTOR inhibitors will be highly active in glioma, and
that clarifying mechanism of action, identifying biomarkers of response, optimizing delivery, and identifying agents that
cooperate to drive cytotoxicity, provides a preclinical rationale to test these agents in patients with GBM. Our aims are:
1. To clarify how tumors recover after initial regression in vivo, and to identify biomarkers of response.
2. Synthesize and test agents that drive rapamycin and RapaLink-1 into the brain.
3. To identify agents that cooperate pharmacologically, to improve the efficacy of RapaLink-1 in glioblastoma.

Public health relevance
Project Narrative We describe a novel mTOR inhibitor, RapaLink-1, that is 1-2 logs more potent that existing mTOR inhibitors, is blood brain barrier permeable, accumulates in glioblastoma tumor cells and shows efficacy in-vivo. We propose a detailed characterization, including analysis of efficacy, identification of response biomarkers, and development and characterization of existing and novel agents that enhance efficacy in combination. Successful completion provides the preclinical rational to initiate a clinical trial of RapaLink-1 in patients with glioblastoma.